The Origins of Alzheimer Disease in African Americans

ABSTRACT
The goal of this proposal is to advance our understanding of the genetic etiology of Alzheimer disease
(AD) risk in understudied and underserved populations. AD is the leading cause of dementia in the elderly
and occurs in all ethnic and racial groups, but most genetic studies for AD have been performed in non-Hispanic
Whites (NHW) of European ancestry. This is problematic, as much smaller studies in African Americans (AA),
who have a higher prevalence of AD compared to NHW, have already revealed differences in risk effect sizes in
known loci (e.g., APOE; ABCA7), indicating multiple unique patterns of risk. Genetic ancestry (including
variability in allele risk frequencies and population specific variants modifying known and novel risk loci), in
addition to environmental/cultural factors and their interactions with genetic risk, likely underlies part of this
heterogeneity. With only a small number of the whole genome sequences in the Alzheimer’s Disease
Sequencing Project (ADSP) coming from AA, increased sample sizes and multiple study designs are needed to
elucidate risk in diverse ancestral populations. Family studies provide a powerful complementary design to case-
control studies that can enhance risk prediction and the detection of novel rare risk variants. Filling these critical
gaps using genetic tools will enhance our understanding of AD risk and provide the basis for identifying
prevention strategies and druggable targets. Including ancestral populations from Africa in particular a unique
cohort of multiplex African AD families enables dissecting risk not only in African populations but also among all
populations with AF ancestry. Our efforts will allow for improved disease prediction, prevention, diagnosis, and
treatment through precision medicine, in AA, African, and other African admixed populations.

Public health relevance
PROJECT NARRATIVE To identify new treatment targets, the genomics of Alzheimerʹs disease (AD) has been examined primarily in non-Hispanic White populations. We propose here a genomics study of AD in multiplex families of African ancestry both from the US and Africa. We will use whole-genome sequencing as well as collect biomarker and cardiovascular disease phenotypic data in these populations together with information about ancestry and to identify genetic variation influencing AD thereby extending AD genetic discoveries to these underrepresented groups.